Chemical Genetic Analysis of RAS Signaling

Abstract
The GTPase RAS functions as a molecular “on/off” switch, existing both in GDP-bound (inactive) and GTP-
bound forms (active). Despite functioning as a simple binary switch, RAS is capable of directing complex and
diverse cellular processes, including proliferation, migration, survival, and T-cell development. Recent work
suggests that the ability of RAS to play complex, often conflicting roles in diverse processes results from
differences in cellular context and and/or subcellular localization of its signaling. We have developed a novel
chemical genetic tool–called Chemically-Inducible Activator of RAS (CIAR)–to study the dynamics of the
signaling networks that are mediated by RAS activity. CIAR allows rapid and dose-dependent activation of
RAS signaling with a cell permeable small molecule. With CIAR, we propose to use targeted, quantitative
phosphoproteomics and transcriptomics to study the fundamental dynamic behavior of RAS-driven signaling.
Subcellularly-localized versions of CIAR will be used to determine the effects of localized RAS activation on the
dynamics of RAS-mediated signaling. We will also delineate the interplay between WT RAS and oncogenic
RAS signaling and the contribution of WT RAS-mediated signaling to direct inhibitors of oncogenic RAS
mutants. Finally, we will develop and use a chemically-controlled toolset for the rapid activation of signaling
enzyme oligomers, which will be used to dissect the role that oligomerization state plays in RAS signaling
dynamics.

Public health relevance
Narra�ve RAS is a central component of many intracellular signaling networks in eukaryotes. Despite the role of misregulated RAS in numerous cancers, many fundamental aspects of RAS-mediated signaling are s�ll poorly understood. Here, we will quan�ta�vely characterize the dynamics of RAS-driven signaling in diﬀerent cellular environments and explore the eﬀects of signaling crosstalk.